Revisiting ReCHARGE: ECHO Follow up on Middle Childhood and Adolescence

Beginning in fall, 2016, the UC Davis pediatric cohort, ReCHARGE, was funded with the new Environmental Influences on Child Health Outcomes (ECHO) Consortium that encompassed close to 80 sites. Now in year 7 of ECHO Phase 1, UC Davis has enrolled ~900 children into ECHO from three neurodevelopmental groups of children with: autism spectrum disorder (ASD), developmental delays (DD) without autistic symptoms, and typical development (TD); uploaded over 55,000 data collection forms to the ECHO Cohort Data Platform, and transferred over 8000 biospecimen aliquots to the ECHO Biorepository, including DNA for SNP arrays, urine for analyzing novel chemicals from common but understudied household products, and blood for multiple uses. The UC Davis ECHO team led a number of analysis proposals, authored/coauthored 40 peer-reviewed papers, with another 50 in-progress. The Team also contributed to developing ECHO policies and participated in and led various working groups, such as Neurodevelopment, Chemical Exposures, Epigenetics, as well as Committees on Publications, Policy Implementation and Evaluation, and others. The ECHO-ReCHARGE cohort focuses on the ECHO area of neurodevelopment, which is facilitated by the UC Davis MIND Institute. In ECHO Phase 2, the UC Davis Aim 1 will: examine environmental exposures including air pollution, greenspace, and home product use; as well as family financial hardship and parental mental health or substance use problems, in associations with externalizing and internalizing behaviors, namely, symptoms of ADHD, anxiety and depression at ages 8-20; and potential modification of exposure-outcome associations by early childhood developmental diagnosis (ASD, DD, TD), age, sex and puberty status. Aim 2 will evaluate the environmental exposures listed above along with childhood exposure to PFAS and plasticizers, for associations with longitudinal trajectories of the above behavioral and emotional outcomes, as well as cognitive skills. Aim 3 will implement the final ECHO protocol with high fidelity, maximize retention, and adhere to all ECHO policies, IRB, HIPAA and other regulations. UC Davis will continue to contribute broadly to the ECHO infrastructure; advance the science through analysis and publications; work to retain participants; and actively participate and play leadership roles in this high-profile, unique program to discover underlying risk and resilience factors for childhood health and development.

Public health relevance
Project Narrative. Many youth are burdened with attention deficits, inattention, hyperactivity, anxiety or depressive mood, and these conditions can have long term serious consequences that impair their ability to succeed in school, obtain and keep productive jobs, get along with their peers, or find happiness. This project seeks to understand and identify some early childhood exposures, behaviors, or experiences that may increase risks for those problems, and ones that may help them avoid these issues. The public health importance of the proposed project is that finding out what changes a child’s risks or improves their outcomes can help public health agencies to design interventions to help children before the problems become severe or even before they know they are affected by these conditions.